Individual Differences in Color Vision Assessed with Chromatic Textures

Veterans with mild traumatic brain injury (mTBI) often report visual problems despite normal or near-normal
performance on clinical tests of afferent vision. Strikingly, a similar pattern is observed in the auditory domain,
which suggests two potentially overlapping explanations for the (multi-)sensory deficits in mTBI: (a) damage to
the ascending sensory pathways produces subtle deficits that may not be detectable on standard clinical tests;
and (b) changes at more central levels of sensory processing or in cognitive, affective, or associative brain
networks lead to deficits in processing complex sensory environments. Therefore, an ideal measure of sensory
capacity in mTBI should account for changes at these different levels of processing. Returning to the domain of
vision, recent research suggests that color vision is highly sensitive to acquired disorders or trauma affecting the
early visual pathway. At the same time, color plays a significant role in higher visual functions such as object
segregation and visual attention. These properties make color vision an ideal candidate for assessment of visual
function in mTBI. However, current tests of color vision focus on detection of (primarily congenital) losses
originating at the retinal color receptors. The proposed study begins to develop a new test of color vision
designed to capture changes at low (e.g., retinal) and high (e.g., cortical) levels of visual processing. The test
relies on discrimination of chromatic textures whose individual elements are assigned an equiluminant shade
along a continuum from pure green to pure red. The distribution of colors follows a statistical pattern such that
discrimination among two textures with opposing patterns relies on the visual system’s ability to extract those
patterns. Different types of patterns are used to probe different aspects of color processing. Pattern extraction is
assumed to rely on a limited number of mechanisms sensitive to different shades of red and/or green and a
‘mixing module’ that allows the mechanisms to be combined in different ways to encode different patterns. A
mathematical model of texture discrimination performance is used to enumerate, for a group of observers: (a)
the number and structure of the low-level mechanisms; (b) each observer’s sensitivity to those mechanisms; and
(c) each observer’s unique mixing proportions. Performance across different chromatic texture patterns is taken
to reflect a given observer’s unique profile of red-green vision. This proposal aims to validate this paradigm in
groups of younger (25-34 yrs.) and older (55-64 yrs.) Veterans with normal color vision, given that low-level color
sensitivity is known to decrease by ~10% per decade of life with considerable individual differences in high-level
color processing within and between age groups. The first specific aim is to determine whether chromatic
texture discrimination captures aspects of color processing beyond those captured by well-established chromatic
sensitivity measurements. Red-green chromatic sensitivity thresholds from the Color Assessment and Diagnosis
(CAD) test will be entered with chromatic texture discrimination thresholds in a factor analytic model, where the
hypothesis is that chromatic texture discrimination thresholds will load on a different factor than CAD thresholds.
A novel ‘suprathreshold’ measure of chromatic sensitivity based on color-defined coherent motion will be
included to capture variation in chromatic sensitivity at higher levels of processing. The second specific aim
will apply the aforementioned mathematical model of chromatic texture discrimination to characterize individual
differences in bottom-up (mechanism sensitivity) and top-down (mechanism mixing) color processing.
Achievement of these aims will allow deployment of color vision tests – texture-based or otherwise – to
characterize the visual deficits in mTBI by providing a baseline for normal variation in color vision at multiple
ages and levels of processing. Notably, the red-green texture discrimination paradigm can be easily extended to
yellow-blue and grayscale vision. The long-term goal for this line of work is to combine texture-based and other
tests of complex visual function with related tests of complex auditory function to determine the extent to which
multisensory deficits at different levels of processing contribute to the functional deficits observed in mTBI.

Public health relevance
Nearly 350,000 United States Military Servicemembers have been diagnosed with a mild traumatic brain injury (mTBI) since the year 2000. Recent surveys suggest that half or more of Veterans with mTBI will report problems with their vision, but visual deficits are often not detected in this population using standard clinical tests. Failure to diagnose and treat these visual deficits may exacerbate or prolong the everyday difficulties experienced by Veterans with mTBI (e.g., reading, driving, or following a visual presentation), presenting a critical barrier to successful rehabilitation and reintegration. In other acquired visual disorders, changes in color vision are often the earliest sign of vision loss. This study develops a new test of color vision designed to capture subtle differences in the processing of color signals at peripheral and central stages of the visual system. This “mutli- stage” approach is geared toward characterizing the complex profile of visual deficits associated with mTBI and can easily be extended to other domains of visual function such as motion or luminance contrast.